Supplement to Lifecourse Patterns of Abuse and Elder Mistreatment (1R01AG059823-01)

In this supplement, we propose to conduct 50 qualitative interviews with adult participants of a longitudinal study on lifecourse patterns of abuse and elder mistreatment. These 60-minute interviews, conducted by telephone or videoconference, will consist of a short structured survey, followed by a series of open-ended questions pertaining to COVID-19 pandemic. We are particularly interested in the effects of state-specific orders of social distancing and self-isolation related to the pandemic on adult child-older parent relationships, particularly when participants are providing support and care for vulnerable older adults, and the mental health, substance use, and resilience of adult children. Research questions broaden the data collection on our parent project to capture dimensions unique to the pandemic but objectives remain within the original scope of the parent study. The specific aims for this application are to (1) identify the unique challenges faced by adult children of formerly abusive parents within the context of COVID-19 shelter-in-place orders and social distancing mandates and (2) discern personal behaviors and social factors associated with the pandemic that influence resilience in adults who were abused. The research is guided by a life course perspective, which provides a foundation from which to assess responses to this major life stressor in relationship to the intergenerational transmission of violence.

Public health relevance
Leveraging existing and newly collected data on risk and resilience processes related to intergenerational patterns of family violence is critical to advancing theories, practices, and policies to help eradicate all forms of abuse and elder mistreatment. Newly proposed research questions pertaining to the COVID-19 pandemic will strengthen and extend work already underway to (1) identify the unique challenges faced by adult children of formerly abusive parents within the context of COVID-19 shelter-in-place orders and social distancing mandates and (2) discern personal behaviors and social factors associated with the pandemic that influence resilience in adults who were abused.